Protein structural disorder and ubiquitination

[unreadable] DESCRIPTION (provided by applicant): Defects in the ubiquitin-proteasome system are implicated in the development of numerous human diseases. Some of the natural substrates for ubiquitination and degradation can induce malignant transformation if not properly removed from the cell. Despite the importance of the ubiquitination process, precise identification of ubiquitination (Ub) sites (i.e. acceptor lysine residues to which a ubiquitin molecule is attached) within substrates of ubiquitin ligases is still experimentally challenging. The development of computational approaches to predict Ub sites from a protein sequence provides an attractive alternative to the experimental methods. Here, we propose to develop a computational algorithm that could predict Ub sites with high precision. First, we will identify new protein Ub sites using a combination of multidimensional protein identification technology (MudPit) and mass spectrometry. Different environmental perturbations, such as heat shock, oxidative stress, DNA damage, and starvation for nutrients, will be introduced in order to increase the coverage of the ubiquitinated proteome. Second, we will use the dataset of new Ub sites to develop a ubiquitination sites predictor. A novel machine learning approach that includes co-training of two predictors having different data representations, and the usage of the unlabeled dataset to increase performance accuracy will be utilized. To our knowledge, this will be the first ubiquitination sites predictor developed to date. Finally, we will apply the predictor to the datasets of cell signaling and cancer-associated proteins to predict new ubiquitination sites and substrates among them. The prediction of intrinsic disorder (ID) will be carried out on the same datasets in order to test the hypothesis about preferential occurrence of Ub sites within ID regions. Annotated disease-related mutations will be extracted from three public databases (MutDB, SWISS-PROT and OMIM) and correlated with the predicted ubiquitination sites. The discovery of mutations in proximity to Ub sites or even those directly affecting Ub sites would lay the basis for formulating and testing biologically meaningful hypotheses about their role in cancer and other diseases. Proteins undergo a wide range of modifications that regulate their activity. One of such modification, ubiquitination, was shown to be involved in various human diseases including cancer, renal diseases (von Hippel-Lindau disease, Liddle syndrome, ischemic acute renal failure), several neurodegenerative diseases (Alzheimer, Parkinson, CAG- expansion disorders). The precise ubiquitination sites in proteins are difficult to detect. We propose to develop a computational approach that could identify such sites with high precision. This would help to develop better drugs that are directed either against the ubiquitinated proteins or against specific sites in these proteins. [unreadable] [unreadable] [unreadable]